The Role of RNA in Defining FUS Specificity and Activity in Phase Separation and Splicing

PROJECT SUMMARY
Fused in sarcoma (FUS) is an abundant nuclear RNA binding protein that helps regulate nearly every level of
RNA processing. FUS activity depends on its ability to specifically bind RNA, however it remains unknown
how it achieves specificity given its affinity for a wide variety of cellular RNA sequences. A striking example
of FUS specificity is on its own pre-mRNA where it binds exclusively near exon 7 to repress exon skipping,
leading to nonsense mediated decay and FUS autoregulation. In neurological diseases amyotrophic lateral
sclerosis (ALS) and frontotemporal dementia (FTD), FUS mislocalizes to the cytoplasm, incorporates into
stress granules, and subsequently forms pathological inclusions. FUS misregulation in ALS/FTD causes
widespread disruption of gene expression including FUS autoregulation, leading to overexpression of FUS and
amplification of pathogenic aggregates. Although RNA binding is central to the physiological and pathological
activities of FUS, the FUS:RNA interaction and its functional outcome remain poorly understood. This proposal
seeks to investigate the FUS:RNA interaction across multiple scales to better understand FUS RNA-binding
preferences and the role of RNA sequence and structure in defining FUS activity. Aim 1 will test FUS binding to
a broad set of synthetic and biological RNA constructs including exon 7 from FUS mRNA. The FUS:RNA
interaction will be characterized using EMSA, fluorescence anisotropy, single molecule FRET and NMR
spectroscopy. This aim will also test the impact of ALS-associated FUS mutations on RNA binding. Aim 2 will
test these RNAs in phase separation assays based on the fact that FUS readily phase separates into liquid
droplets in an RNA-dependent manner. How different RNAs and FUS variants affect the size, number,
shape, and fluidity of FUS droplets and how this corresponds to their molecular interactions determined in aim
1 will be observed. Finally, aim 3 will test the RNA dependence of FUS splicing activity in neuroblastoma and
neuronal cells using an RT-PCR based minigene reporter assay and real-time single molecule imaging.
Special attention will be given to FUS autoregulation due to its relevance to ALS/FTD. Together, these aims
will help uncover the mechanism of FUS specificity and activity. The proposed research will primarily be carried
out in the lab of Dr. Sua Myong with support and co-mentorship from Dr. Jiou Wang. Dr. Myong will provide
expertise in RNA-protein biophysics and single molecule methods while Dr. Wang has expertise in
neurobiology and neurodegeneration, specifically ALS/FTD. Between the sponsors, collaborators, and
scientific community at Johns Hopkins the applicant will receive the mentorship, technical training, and access
to resources and expertise necessary to accomplish the proposed project. Additionally, the proposal outlines
many planned activities for career development including mentorship, teaching, and scientific communication.
Overall, this training plan has been designed to prepare the applicant for an independent research career.

Public health relevance
PROJECT NARRATIVE Fused in sarcoma (FUS) is an abundant RNA-binding protein that regulates nearly every step of gene expression and becomes highly dysregulated in neurodegenerative diseases amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). This proposal seeks to characterize the interaction of FUS with RNA to understand how FUS binds RNA specifically in cells and how RNA sequence and structure impact FUS activity in phase separation and splicing. The results of this work will advance our fundamental understanding of FUS activity and the role of RNA in healthy and disease conditions.